T. cruzi: pathogenesis modulation by eicosanoids

targets for the treatment of cardiovascular disease and our current studies are likely to provide additional targets for the treatment of this important human parasitic disease. Project Description Page 6